Do peers enhance or detract progress in group MI? A look into emerging adult brain and behavior

PROJECT SUMMARY
At this time, alcohol is the top substance used by US emerging adults under the legal drinking age (underage
emerging adults; U-EA; ages 18-20). While drinking rates had recently been trending downward, 2021 national
data reflect rises in youth drinking across all metrics. This is highly consequential in terms of youth safety and
neurodevelopment. One of the central challenges of U-EA alcohol use is that youth are unlikely to seek,
receive, or complete indicated alcohol intervention. In turn, it is imperative to find brief, effective interventions to
impactfully intervene with U-EA hazardous alcohol use. Additionally, the developmental neuroscience literature
robustly reflects that peers hold higher neural salience during this developmental window, as evidenced by
youths’ differential neural response in conditions with real and/or simulated peers, even when those peers
were not friends, and particularly in the context of alcohol. Furthermore, studies are recognizing that peers
concomitantly activate positive (prosocial) neural and behavioral responses in this age group, and this has
been observed in conditions of negative and positive peer feedback. The role of negative and positive peer
feedback is consequential given that one of most widely-used U-EA intervention service delivery methods are
group-based formats. Here, we aim to build upon PI Feldstein Ewing’s 15 year history of continuous NIH-
funding in youth translational (brain:behavioral) approaches evaluating the relationship between youth within-
session factors, youth neural response, and subsequent behavior change. Across independent samples, our
team has found a pattern of distinct developmental brain response to MI-based interventions, largely localized
to default mode network (DMN) regions [precuneus, posterior central cortex (PCC)]. Critical to this proposal,
this observed DMN activation to examined within-session factors (client language; therapist language) has
been significantly associated with post-treatment youth substance-related behavior change. We thus respond
to PAR-21-280 Notice of Special Interest: “Dyadic Interpersonal Process and Biopsychosocial Outcomes” and
propose to use functional magnetic resonance imaging (fMRI) to disaggregate the interaction between U-EA
brain response among group MI participants (peer dyads) and their intervention outcomes in the
underexamined, but widely-utilized group MI context. In this study, we will evaluate how peer-to-peer dyadic
exchanges during group MI interventions are associated with youth brain-based and behavior changes (Aim 1)
and evaluate prospective relationships between youth brain response and behavior change (Aim 2).
data are crucial for guiding and improving behavioral intervention programming for U-EA engaged in
hazardous alcohol use.
These

Public health relevance
PROJECT NARRATIVE Alcohol is the top substance used by US emerging adults under the legal drinking age (underage emerging adults; U-EA; ages 18-20). We respond to PAR-21-280 and propose to use functional magnetic resonance imaging (fMRI) to disaggregate the interaction between U-EA brain response among group MI participants (peer dyads) and their intervention outcomes in the underexamined, but widely-utilized group MI context. In this study, we will evaluate how peer-to-peer dyadic exchanges during group MI interventions are associated with youth brain-based and behavior changes (Aim 1) and evaluate prospective relationships between youth brain response and behavior change (Aim 2).